Characterization of the lens fiber cell tricellular junctional complex and its dependency on delta-catenin

Abstract: Lens fiber cells are organized into a regular hexagonal array which promotes the transparency and
refractive power of the lens. Junctional adhesion complexes are thought to facilitate this cellular organization
but most efforts have focused on proteins and their associated complexes localized within bicellular membranes,
where two cell membranes meet. The repeating hexagonal cellular pattern also naturally creates a different type
of junction at the confluence of three cells called the tricellular junction which, in other epithelia, is inhabited by
a distinct complement of proteins. However, the majority of what is known about these distinctive proteins are
part of tricellular tight-junctions (tTJs) while little knowledge exists on the protein complexes that make up
tricellular adherens junctions (tAJs) in vertebrates. The tAJ of lens fiber cells are large due to their extreme length
and makes them an ideal model for elucidating the biology of this structure. We have recently demonstrated
that the cadherin-associated protein δ-catenin is among proteins that specifically localize to the tricellular, but
not the bicellular junctions, of lens fiber cells in mice. Furthermore, preliminary proteomic data suggests δ-
catenin associates with a distinct set of proteins that include members of desmosomal junctions and GTPase
signaling regulators. Importantly, human mutations within the encoding gene of δ-catenin, CTNND2, are
associated with both cortical cataracts and high myopia, supporting the notion that both δ-catenin and tricellular
junctions are important for lens physiology. However, what functional role δ-catenin plays in the lens or within
the tricellular junctional complex of any tissue has not been assessed. In this exploratory proposal, the hypothesis
that δ-catenin is required for the normal organization of the tricellular adherens junctional complex of lens fiber
cells which preserves lens refraction and transparency will be tested with two aims. In the first aim, the
requirement of δ-catenin for lens function will be tested. Additionally, we will perform a series of in vivo and ex
vivo interaction assays to test for the presence of hypothesized candidate protein interactions within the tAJ. This
analysis will be performed in lens fiber cell lysates and tissue of control or mutant mice lacking functional δ-
catenin and followed up with super-resolution fluorescent microscopy to determine tAJ localization. In the
second aim, we will test whether the δ-catenin associated protein complex is dependent or independent of the
tAJ residing protein afadin and/or mechanical force. Preliminary data indicates that afadin localizes exclusively
to tAJs and not bicellular membranes of lens fiber cells and is required for lens fiber cell organization and
transparency. The complement of tAJ proteins that depend on afadin to associate with δ-catenin will be
determined from proteomic analysis and high-resolution microscopy. Together these experiments will be the
first to characterize the function of δ-catenin in the lens and identify the constituent proteins of the tricellular
adherens junctional complex of lens fiber cells.

Public health relevance
Project Narrative: The proposed studies are relevant to public health because they investigate the mechanisms that underlie the biology of the lens, its constituent cellular proteins, and the cause of cortical cataracts. Specifically, it tests hypotheses that focus on the role of specialized proteins that make up the adhesive structures found where three individual cells meet. Because the function of these proteins can be disrupted in diseases of the lens, such as cataracts, the knowledge acquired from this study can help understand why these diseases occur.